University of Colorado Cancer Center Support Grant

ABSTRACT
The University of Colorado Cancer Center (UCCC) drives cancer discovery and innovation, translates these
findings to the clinic, leads in patient-centered care, reduces health disparities, trains the next generation of
cancer focused scientists, and strives to optimize the impact on our catchment area – the State of Colorado.
UCCC has benefited from a generous increase in funding and has made significant investments into all programs
and structures. The highlights of recent progress include: 1) completion and deployment of a comprehensive
strategic plan; 2) restructure of the programs; 3) recruitment of dynamic and accomplished new leaders including
a Director (Schulick) and a second Deputy Director (Bradley), and recruitment of inaugural Associate Directors
of Community Outreach and Engagement, as well as Informatics and Data Science; 4) establishment of two
cross cutting themes of Cancer and Aging and Cancer and Metabolism; and 5) overhaul of UCCC membership
criteria to better focus the activities of members and to increase emphasis on mentoring. This large infusion of
resources and restructuring have better enabled multiple innovative discoveries in the laboratories to be brought
to the bedside through investigator-initiated trials, FDA approval, and establishment of new standards of care.
They have also enabled successful bi-directional community outreach and engagement and population-based
programs within the catchment, with continued focus on increasing inclusion and diversity. The physical space,
organizational capabilities, transdisciplinary collaboration and coordination, cancer focus, and institutional
resources have all been improved, setting UCCC on a trajectory of success well into the future. In the next
funding period, UCCC will focus on the strategic aims, goals, as well as the 21 specific strategies outlined in the
strategic plan. Highlights of these strategies include efforts to: 1) provide outstanding research infrastructure
and state-of the art shared resources; 2) expand clinical research, clinical trials and investigator-initiated trials;
3) expand research and interventions across programs to address health outcomes, disparities, and underserved
populations; 4) nurture the pipeline of prospective oncology researchers, clinicians, and administrators;
strengthen alignment and collaboration within the UCCC and across all sites; and 5) grow philanthropic support.
As necessary, UCCC leadership will modify the course to adjust to unexpected challenges (e.g., COVID) and
opportunities (e.g., campus-wide initiative to build data science).

Public health relevance
PROJECT NARRATIVE The University of Colorado Cancer Center (UCCC) is an NCI-designated matrix center that brings together 263 cancer researchers from two universities and four clinical entities to drive cancer discovery and innovation. UCCC addresses the cancer needs of its catchment, the State of Colorado, guided by its vision to prevent and conquer cancer. Together. UCCC's mission is to unite its community to overcome cancer through innovation, discovery, prevention, early detection, multidisciplinary care, and education. Exemplary research and adroit leadership, propelled by significant institutional investment has led to impactful innovations in cancer biology that translated into preventative, diagnostic and therapeutic strategies proven in clinical trials, approved by the FDA, and then disseminated to improve the standard of care. UCCC seeks to address the needs of underserved populations by providing targeted, culturally appropriate behavioral interventions, colorectal cancer screenings, and by shaping state tobacco control legislation. CCSG renewal and continuation of institutional commitments of funds and space will allow a continued upward trajectory and enhance the fight against cancer in Colorado.